NORMAL AND ABNORMAL HYPOTHALAMIC-PITUITARY-ADRENAL FUNCTION

We have continued to define the success rate of transphenoidal surgery in curing Cushing's Disease, our current rate being approximately 80%.